Cell Membrane Resealing in Inflammatory Myopathy

Project Summary
Idiopathic inflammatory myopathies (IIM) are a group of inflammatory disorders characterized by muscle
weakness and are associated with significant morbidity and mortality. Inflammation and muscle injury are the
central features observed in histology. Both adaptive and innate immune responses are involved in the
pathogenesis of IIM but the pathogenic mechanisms are not yet well defined. Current treatment options for
myositis are limited and focus on the use of broad-spectrum immunosuppressive drugs that often lead to
significant complications. Previous studies with synaptotagmin VII null (SytVII-/-) mice displayed impaired
sarcolemmal membrane repair capacity and developed mild myositis at two months in age, suggesting that
antigen presentation of internal skeletal muscle proteins may play a role in initiating or exacerbating myositis.
We generated a more robust model of inflammatory myositis by combining the SytVII-/- model with scurfy mice
that have a regulatory T cell deficiency (FoxP3-/Y/SytVII-/-). Adoptive transfer of lymph node cells from FoxP3-
/Y/SytVII-/- mice into Rag-1-/- mice lacking both T- and B-cells results in significant muscle inflammation. This
finding also links the progression of myositis with defects in sarcolemmal membrane repair. The sarcolemmal
membrane repair response is a conserved response necessary to restore membrane integrity in myocytes as
part of normal cellular physiology. Defects in membrane repair are linked to a variety of muscle diseases. Our
previous work helped identify intracellular proteins as critical components of the membrane repair process. This
application builds on our recently published work and new preliminary studies that identified novel autoantibodies
in myositis patients against proteins that are essential for the membrane repair. We also established that these
antibodies can alter the membrane repair capacity of skeletal muscle. We hypothesize that compromised
membrane repair leads to exposure of these membrane repair proteins to the extracellular space and that the
autoantibodies produced against these proteins further compromise membrane repair and exacerbate
inflammation during myositis. We will test this hypothesis with three specific aims. Aim 1 will define the
mechanistic role of TRIM antibodies on membrane fragility associated with myositis using various mouse models
with compromised membrane repair. Aim 2 will determine if patients’ autoantibodies directed against skeletal
muscle proteins linked to the membrane repair process are sufficient to compromise membrane repair. Aim 3
will test the efficacy of increasing membrane repair capacity of skeletal muscle as a novel therapeutic strategy
to treat myositis. Our findings that compromised membrane repair contributes to the pathogenesis of myositis
suggests a potential therapeutic strategy that could target multiple IIM.

Public health relevance
Project Narrative Idiopathic inflammatory myopathies (IIM) such as dermatomyositis are a group of inflammatory disorders characterized by muscle weakness and associated with significant morbidity and mortality with limited treatment options that focus on the use of broad-spectrum immunosuppressive drugs with significant complications. Myositis and other IIM represent a truly unmet medical need as there is currently no cure for any IIM. Our research effort proposed in this project will test if a new mechanism of muscle cell damage contributes to the progression of myositis and generate proof-of-principle data that, by increasing the membrane repair capacity of muscle cells, may provide an effective therapy for the treatment of myositis.